ALCOHOL EPIDEMIOLOGIC DATA SYSTEM

The purpose of this contract is to operate an alcohol epidemiologic data system which supports the Division of Biometry and Epidemiology in (1) maintaining and acquiring additional alcohol-related national data sets; (2) conducting research studies utilizing alcohol epidemiologic data; (3) providing analytic reports annually on liver cirrhosis mortality, alcohol- related fatal and other traffic accidents, and other subjects; (4) responding to alcohol epidemiologic data questions; and (5) establishing and maintaining epidemiologic research consultants.